Developing Novel Tools for Precision Targeting of Pro-Autoimmune Th17 Cells

PROJECT SUMMARY
Autoimmune diseases, affecting over 23 million Americans, occur when the immune system attacks the body's
own tissues. Traditional treatments often involve non-selective immunosuppressants, leading to severe side
effects. Recent advancements in biologics, such as IL-23 monoclonal antibodies, have improved treatment
selectivity by targeting pathogenic cells like IL-17 producing Th17 cells. However, these therapies can increase
infection susceptibility due to the dual role of IL-23-dependent Th17 cells in autoimmunity and infection control.
Although pro-autoimmune and anti-infection Th17 cells were previously perceived as indistinguishable, the FDA-
approved drug clofazimine (CLF) was identified as the first pro-autoimmune Th17-selective inhibitor without
affecting anti-infection Th17 cells. However, CLF has adverse effects compromising patient compliance. One
strategy is to continue screening small molecule compounds or FDA-approved drugs, while another approach
involves designing and synthesizing inhibitors based on the specific targets of CLF in pro-autoimmune Th17
cells. Thus, the objective of this proposal is to establish a high-throughput drug screening pipeline to identify
selective inhibitors of pro-autoimmune Th17 cells and to generate reagents for determining the cellular targets
of CLF. The rationale is that creating a high-throughput screening system and facilitating CLF target identification
will accelerate the discovery of small molecule inhibitors that selectively target pro-autoimmune Th17 cells while
sparing anti-infection Th17 cells. This approach will address the urgent need for treatments with better efficacy
and safety profiles for autoimmune disease patients. Aim 1 focuses on establishing a high-throughput drug
screening pipeline by generating and validating a novel reporter mouse model. Aim 2 involves generating
biotinylated CLF to identify its molecular targets in pro-autoimmune Th17 cells, enabling the pull-down of CLF-
interacting proteins for identification by mass spectrometry. The significance of this study lies in its potential to
discover highly selective inhibitors for pro-autoimmune Th17 cells, thereby reducing the adverse effects
associated with current treatments for autoimmune diseases. The innovation of this project includes the
development of a novel high-throughput screening pipeline and the creation of biotinylated CLF for precise target
identification. These advancements could revolutionize the therapeutic landscape for autoimmune diseases,
offering more effective and safer treatment options.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because it aims to develop more precise treatments for autoimmune diseases, potentially reducing side effects and improving the quality of life for millions of Americans. The proposed research is relevant to the NIH’s mission by advancing our understanding and ability to selectively target harmful immune cells, thereby enhancing health, lengthening life, and reducing illness and disability.